U-RISE at PVAMU

URISE at PVAMU PI/PD: Regisford
The increasing need for a well-trained STEM workforce, made more poignant during this COVID-19 pandemic,
also requires a diverse population to meet the future needs and challenges in the biomedical sciences. An
Undergraduate Research Training Initiative for Student Enhancement (U-RISE) program will reach a large racial
and ethnic underrepresented (UR) population with disadvantaged socio-economic backgrounds and first-generation
college students at Prairie View A&M University (PVAMU), a historically black university. Moreover, PVAMU's
promotion of undergraduate engagement in research, and its established collaborations with surrounding research-
intensive universities, provide a robust learning environment that will strongly support a U-RISE program.
Although student enrollment in biomedical science disciplines such as Biology and Chemistry are relatively high,
less than 10% declare an interest in graduate school; a conundrum that may be due to lack of exposure and
preparation for the rigors of graduate school. Therefore, the overarching goal of this proposed U-RISE program
is to enhance student participation and preparation in the biomedical sciences for matriculation into highly
competitive PhD programs and ultimately, a biomedical science research career. This goal will be
accomplished by the following specific objectives: (1) Provide an enriched interdisciplinary research culture that
exposes all U-RISE trainees to hands-on research for three consecutive years; (2) Enhance the academic
curriculum that fosters advancement of 80% of U-RISE at PVAMU trainees to a biomedical science graduate
program and (3) Create a nurturing learning community by engaging U-RISE at PVAMU trainees in a
multidimensional mentoring program, that will lead to improved retention (90% of U-RISE trainees) and
graduation rate (90% of U-RISE trainees). Program elements will include professional skills development of all U-
RISE trainees to enhance their competitiveness. We have built a multidisciplinary team of faculty, research
professors/scientists, and external collaborators to create a nurturing and stimulating culture that will evoke
evidence-based student support and motivation practices. Each year, four sophomores will be selected to join the
U-RISE at PVAMU program. Selection of U-RISE trainees will be based on the following criteria: the students'
academic record, member of a racial and ethnic UR population, a declared major in a biomedical science discipline,
and a desire to attend graduate school in the biomedical sciences. The expected outcomes are (1) an increase in the
number of students who become engaged in biomedical science research; (2) an extensive academic preparation of
U-RISE at PVAMU trainees for matriculation into a competitive graduate program within one year after graduation;
and (3) the creation of a replicable, transportable, evidence-based model that promotes preparation of
undergraduates from UR populations for biomedical science research careers. Ultimately, the U-RISE at PVAMU
program will contribute to increased diversity in the biomedical sciences workforce.

Public health relevance
U-RISE at PVAMU PI: E. Gloria C. Regisford, PhD Project Narrative: An historically black University/College (HBCU), Prairie View A&M University (PVAMU) is evolving into an institution that places emphasis on engaging all undergraduates in nondidactic activities, such as research experiences/internships. In alignment with this mission, the goal of the proposed U-RISE at PVAMU program is to enhance student participation and preparation in the biomedical sciences for matriculation into highly competitive PhD programs and ultimately, a research career. The U-RISE at PVAMU program will contribute to the enrichment of the academic and research culture at this institution and will lead to an increase in PhD program matriculation and completion, and ultimatelyto a more diverse biomedical research workforce.